Modulation of Herpes Simplex Virus Pathogenesis by Leucine Rich Repeat Kinase 2

PROJECT SUMMARY
In the United States, herpes simplex virus type 1 (HSV-1) infects more than half the adult population and is the
leading cause of viral encephalitis and infectious blindness. Yet, the host factors contributing to the most
severe manifestations of HSV-1 remain unclear. Inflammasomes, a recently discovered antiviral innate
immune defense, and the production of two inflammasome cytokines (interleukin (IL)-1β and IL-18) are critical
in HSV-1 control and pathogenesis. However, how inflammasomes are regulated during HSV-1 infection is
poorly understood. Recently, leucine-rich repeat kinase 2 (LRRK2) has emerged as a possible regulator of
inflammasome signaling. LRRK2 has been studied extensively because specific alleles are associated with
Parkinson’s disease, Crohn’s disease, cancer, and leprosy. Despite the disease associations, the precise
function of LRRK2 and how it mediates disease are unknown. Evidence for a role in the immune response
include that LRRK2 is highly expressed on immune cells, is upregulated in response to infection, and was
recently shown to modulate the NLRC4 inflammasome in response to bacterial infection. We recently
demonstrated that NLRP3 is critical in inflammasome activation by HSV-1, and our preliminary data indicate
that LRRK2 enhances NLRP3 signaling. We found that the common LRRK2 mutation G2019S enhances HSV-
1 pathology in mice without altering viral replication. These results point to a novel role for LRRK2 in
inflammasome signaling and HSV-1 pathogenesis. We hypothesize that LRRK2 modulates inflammasome
signaling in response to HSV-1 infection and that the G2019S mutation further enhances inflammasome
activation in vivo, leading to more severe eye, skin, and central nervous system (CNS) pathology after HSV-1
infection. LRRK2 has not been studied in human viral infection, and these represent the first studies to define
its role in the pathogenesis of a common neurotropic human viral infection. In Aim 1, we will identify how
LRRK2 associates with NLRP3, the critical inflammasome adapter in HSV-1 infection, and how mutations in
LRRK2 alter inflammasome signaling in the context of HSV-1 infection. We will accomplish this by using
targeted mutagenesis in a transfection model of inflammasome signaling and by studying inflammasome
activation after HSV-1 infection of cell lines stably expressing LRRK2 mutants. For Aim 2, we will determine
how LRRK2 alters the inflammasome response to HSV-1 using LRRK2 transgenic mice and mice with
inflammasome gene disruptions. Additionally, the PI will gain critical skills and expertise necessary to study the
innate immune response to HSV-1 and other herpesviruses. These learning objectives will be accomplished
through formal coursework, scientific programing, and direct mentorship by experts in viral and murine
immunology, herpesvirology, and biostatistics. The proposed career development plan and research aims will
provide a pathway to a career as an independent investigator studying the interactions between herpesviruses
and the innate immune system.

Public health relevance
Project Narrative Herpes simplex virus type 1 (HSV-1) infects more than half the adult population of the United States and remains the most common cause of viral encephalitis and infectious blindness, yet the pathogenesis of these most severe manifestations remain unclear. We have identified leucine-rich repeat kinase 2 (LRRK2) as a novel pathogenic determinant of severe HSV-1 infection. We propose to determine how LRRK2 and the common LRRK2 mutation, G2019S, alter the innate immune response to HSV-1, expanding our understanding of severe herpesvirus pathology and finding novel therapeutic opportunities to ameliorate the most morbid outcomes caused by this ubiquitous virus.